Motion Processing by Interactions of Receptive Field Center and Surround in Primate Retinal Ganglion Cells

PROJECT SUMMARY
The overall goal of this proposal is to understand the role of interactions between the receptive field center
and surround in encoding motion signals in sparsely expressed retinal ganglion cells of the macaque monkey
retina. Studies of primate retinal ganglion cell physiologies have largely been limited to 5 dominantly
expressed types. This proposal will contribute to our understanding of three poorly understood and sparsely
expressed ganglion cell types: the broad thorny, the ON smooth monostratified, and the OFF smooth
monostratified. These three types will be characterized in terms of center-surround interactions that
contribute to each ganglion cell’s functional output.
The proposed research has two specific aims:
1) To determine whether surround motion facilitates spiking outputs of smooth monostratified ganglion cells.
I will record synaptic inputs and spiking outputs of smooth monostratified ganglion cells to measure
ganglion cell sensitivity when a motion stimulus is presented to the surround. I will test the specific
hypothesis that despite showing a traditionally suppressive surround to stationary spots, the smooth
monostratified cell’s spiking output is facilitated by motion in the surround.
2) To determine whether center and surround interact to create selectivity for object motion in the broad
thorny ganglion cell. I will measure synaptic inputs and spiking outputs of the broad thorny ganglion cell to
determine whether motion in the broad thorny surround is suppressive to all visual inputs except object
motion. My experiments will test the specific hypothesis that surround motion makes the broad thorny
sensitive to differential motion.

Public health relevance
Project Narrative The studies described in this proposal are relevant to ongoing research related to receptive field structure and function in primate sensory systems. The macaque monkey retina shares a substantial amount of its anatomy with the human retina (Kolb et al., 1992) allowing my findings to inform our understanding of the human visual system. Determining novel outputs of primate retina will contribute to our understanding of cortical vision, as well as inform the design of the next generation of retinal prostheses.